ETS1 function in mature innate lymphoid cells

? DESCRIPTION (provided by applicant): Natural killer (NK) cells play a critical role in immunity to some viruses and they protect against hematopoietic malignancy but their uncontrolled activity can lead to pathology due to excess cytokine production and inflammation. One goal of our research is to identify the transcriptional networks that control the development and function of NK cells. Previous studies from our laboratory showed that the ETS1 transcription factor is an important regulator of NK cell development and function and limits activation of NK cells in response to endogenous cytokine. In this grant, mice with a conditional allele of Ets1 will be used to delete Ets1 from mature NK cells providing a model system that will allow us to test the hypothesis that ETS1 has distinct but essential requirements during development, maturation, and activation of NK cells. An understanding of the molecular mechanisms controlling development and activation of NK cells will provide a foundation on which to control their function in situations of immune deficiency or hyper-activity when control of NK cell function would be beneficial, such as for immunotherapy.

Public health relevance
PUBLIC HEALTH RELEVANCE: Natural killer (NK) cells are non-B and non-T lymphocytes that are essential for clearance of certain viruses and protection from hematopoietic malignancy. ETS1 is required for proper development of NK cells and the few NK cells that persist in the absence of ETS1 are hyper-responsive to cytokine stimulation. Here will determine whether ETS1 is required in mature NK cells for their effector maturation and function or whether the altered selection of ETS1-deficient NK cells underlies they altered phenotype and hypersensitivity.